Role of Grail in colon inflammation and tumorigenesis

PROJECT SUMMARY/ABSTRACT
Chronic intestinal inflammation is a major risk factor for the development of colorectal cancer (CRC). It is well-
acknowledged that pro-inflammatory cytokines derived from immune cells play critical roles in almost every
developmental stage of inflammation-induced cancers including CRC; however, molecular and cellular
mechanisms underlying chronic intestinal inflammation leading to tumorigenesis are still being uncovered.
Thus, understanding the mechanisms that control inflammatory responses of mucosal immune cells can be
beneficial for the treatment of inflammation-associated CRC.
Our preliminary results have revealed the potential role of E3 ligase, gene related to anergy in lymphocyte
(Grail), in maintaining intestinal homeostasis and controlling carcinogenesis. Studies in both CRC murine
models and patients show a correlation between Grail expression in colon and reduction of intestinal
inflammation and tumor growth, suggesting the role of Grail in controlling intestinal inflammation and
importantly projecting Grail as a potential marker for diagnosis of CRC. We detected more severe CRC growth
in Grail knockout (KO) mice compared to wild-type (WT) mice, which was associated with increased
expression of immune cell derived pro-inflammatory cytokines in the colon. Moreover, Grail expression in
hematopoietic cells, particular in T cells, is important to control CRC. Remarkably, we detected a higher
number of interleukin (IL)-17 producing T follicular helper (Tfh)17 cells in colons of tumor-bearing Grail KO
mice and their percentage positively correlated with cancer severity. Similarly, we detected a higher number of
Grail-insufficient Tfh17 cells in patients with advanced CRC compared to patients with early stage of disease,
suggesting a new role for Tfh17 cells in promoting intestinal chronic inflammation and neoplastic diseases.
Interestingly, elevated numbers of Tfh17 cells in Grail KO mice were associated with the accumulation of Th17
and B cells, indicating that Tfh cells could engage in crosstalk with other pro-carcinogenic immune cells. We
propose a central hypothesis that Grail maintains intestinal homeostasis by controlling the activity of
pro-inflammatory mucosal Tfh17 cells.
In Aim 1, we will determine the link between Grail expression in Tfh cells and intestinal tumorigenesis. In Aim
2, we will examine the mechanism(s) whereby Grail deficient Tfh17 cells contribute to colon cancer
development. In both aims, we will utilize gene KO approaches and Bcl6/IL17/IFN-reporter mice.
The implication from this work is significant since it will provide novel insights into the genetic link between
inflammation and cancer, define a new marker for early detection of inflammation-associated CRC, and guide
the development of effective colon cancer immunotherapies.

Public health relevance
PROJECT NARRATIVE Chronic intestinal inflammation is a critical risk factor for the development of colon cancer; however, molecular and cellular mechanisms underlying chronic intestinal inflammation are still being uncovered. The proposed research will allow us to validate the importance of gene related to anergy in lymphocyte (Grail) expression in mucosal T follicular helper cells and its role in regulating the balance between intestinal homeostasis and inflammation. The implication from this work is significant, since it will provide novel insights into the genetic link between inflammation and cancer and project Grail as a potential marker for diagnosis of intestinal inflammation.